Natural History of Shoulder Pathology in Wheelchair Users

PROJECT SUMMARY/ABSTRACT
This competitive renewal 1) expands on a prospective longitudinal study that defines the natural history of
shoulder pathology in manual wheelchair users and an age and sex matched able-bodied referent group, 2)
improves the arm use metrics measured during daily living, and 3) determines risk factors of arm use that
accelerate shoulder pathology and pain progression beyond that of natural aging. Additionally, this proposal
performs a large retrospective population-based cohort study to investigate the risks of comorbidities and
medication to a future clinical diagnosis of shoulder pathology or pain. Abundant evidence exists that
individuals with spinal cord injury who use manual wheelchairs are much more likely than age matched able-
bodied individuals to have rotator cuff pathology and/or shoulder pain. This clinical problem has been receiving
attention for decades, yet shoulder pain and dysfunction continues at unacceptably high rates. To maintain the
health and independence of a population that relies on their upper extremities for all activities of daily living, our
objective is to define the natural history of rotator cuff disease in MWC users with the long-term goal of
advancing evidence-based guidelines to decelerate the disease progression. The rate of pathology
progression is largely unknown for MWC users, especially early in the disease when nonsurgical interventions
may be appropriate. Aim 1 addresses this need by tracking the progression of rotator cuff tendinopathy, partial
tears, and pain worsening while quantifying the effect of sex, SCI lesion level, and time since SCI. Inarguably,
higher rotator cuff pathology rates among manual wheelchair users is attributable to the altered shoulder
function during daily living. However, clinical care would be improved if it was known which extrinsic factors of
daily arm use differentiated MWC users whose pathology progression was more accelerated from those whose
pathology did not progress or progressed more slowly. Aim 2 uses wearable sensor technologies to determine
the association between daily arm use (arm posture, repetitive movement, and recovery) and progression of
rotator cuff pathology and pain. Intrinsic factors, including comorbidities and medication use, have been
associated with tendon pathology in the able-bodied literature but they are unstudied in the spinal cord injured
population. Therefore, Aim 3 will evaluate the contribution of comorbidities and medication use to the onset of
rotator cuff pathology and pain in a population-based cohort. By studying factors that differentiate those who
have increased rates of pathology progression from those with stable or improving pathology; actionable
intrinsic and extrinsic risk factors can be defined. These steps are fundamental for providing a basis for patient
education and rehabilitation strategies. By focusing on the early stages of rotator cuff pathology, this study is
likely to lead to rehabilitation strategies to implement prior to the development of shoulder dysfunction among
individuals who rely on their shoulders for independence.

Public health relevance
PROJECT NARRATIVE Aging causes shoulder tendons to deteriorate for all people, but for people with spinal cord injuries who use a manual wheelchair, shoulder tendons will tear and cause pain at a younger age and higher rate than people without physical disabilities. Understanding what factors worsen the health of the shoulder tendons will inform early interventions to protect shoulders and keep them free from pain. This study will follow two groups of people, manual wheelchair users and able-bodied adults, while looking for differences in how they use their arms, the medications they use, and their general health indicators to determine which of these factors are related to worsening tendon tears in the shoulder.